Subtype-Selective Metabotropic Glutamate Receptor PET Ligands

Project Summary. The physiological function of mGluR2 is to negatively regulate endogenous glutamate release and
protect neurons against excitotoxicity. Therefore pharmacological modulation of mGluR2 represents an attractive
therapeutic approach for the treatment of neurological disorders and neurodegenerative diseases, including
Parkinson’s disease, Alzheimer’s disease and related dementias (ADRD). Positron emission tomography (PET) is
capable of quantifying biochemical processes in vivo, and a suitable mGluR2 ligand would substantially improve our
understanding of mGluR2-mediated signaling pathway under different pathophysiological CNS disorders, otherwise
inaccessible by ex vivo (destructive) analysis. Quantification of mGluR2 in living brain by PET would provide the
assessment of distribution, target engagement and pharmacodynamic response of novel mGluR2-targeted
neurotherapeutics. To date, no successful examples have been demonstrated to image mGluR2 in humans for drug
discovery and clinical use, representing a significant deficiency of our ability to study this target in vivo. Therefore, we
propose to develop a novel PET ligand that can fill this void, as the first translational imaging tool.
We are the first groups to develop negative allosteric modulator (NAM) based mGluR2 ligands in cross-species
PET studies, including [11C]QCA. However, this ligand was discontinued due to low brain penetration and marginal
binding specificity in vivo. As our next generation, we identified a lead molecule, MG2-2112, which showed high
binding affinity and excellent selectivity. Our preliminary evaluation confirmed that we have overcome the two major
obstacles for mGluR2 ligand development by achieving: 1) substantially-improved binding affinity, representing the
best compound to date; and 2) high brain permeability and target specificity (characteristic high uptake in mGluR2-
rich striatum and low in mGluR2-poor thalamus/pons). Though MG2-2112 is a promising lead, we are not clear if it is
satisfactory for PET quantification in cross-species study for drug discovery and clinical translation. Thus, we will
advance MG2-2112 as a benchmark and concurrently prepare a series of mGluR2-specific PET ligands. Further
optimization for improved binding specificity and proper brain kinetics, as well as proof-of-concept validations on
human brain tissues, are sought to identify optimal mGluR2 ligands and support target engagement study and efficacy
measurement in drug discovery. The impact of this work is not only to develop the first successful highly-specific
mGluR2 PET ligand for the study of neurological disorders and neurodegenerative diseases-related biological
processes, but also ultimately, via PET imaging validation in higher species, to advance this ligand for potential clinical
translation and monitor target response and safety margins of novel neurotherapeutics for neurodegenerative
diseases, including AD.

Public health relevance
Project Narrative As the burden of neurological disorders and neurodegenerative diseases in the United States and worldwide is high, there is a critical need to discover and perform an initial evaluation of molecular imaging biomarkers and/or biomarker signatures, such as positron emission tomography (PET) imaging tools, to support the clinical development and translation of novel neurotherapeutics. This work will identify, design, and evaluate subtype- selective metabotropic receptor PET ligands to deliver candidate biomarkers for definitive analytical and clinical validation studies, facilitating drug discovery and target engagement study of novel neurotherapeutics.